Inflammatory Caspases in Innate Immunity and Inflammation

ABSTRACT
Aspergillus fumigatus (A. fumigatus) is an important human fungal pathogen which is responsible for
significant morbidity and mortality, particularly among immunocompromised patients. In recent years, we
have made important progress in understanding the molecular mechanisms that regulate sensing of
pathogens such as A. fumigatus by pattern-recognition receptors (PRRs), including Toll-like receptors (TLRs),
NOD-like receptors (NLRs), and AIM2-like receptors (ALRs). Certain members of the NLR and ALR family
assemble a cytoplasmic multi-protein complex termed the ‘inflammasome’, which activates caspase-1 and
induces maturation and secretion of the pro-inflammatory cytokines IL-1β and IL-18 and drives pyroptotic cell
death. The inflammasome plays critical roles in clearing fungal infections.
My laboratory is a founding member of the inflammasome field and continues to radically advance this
research area with our pivotal studies, elucidating the mechanisms driving inflammasome activation and
identifying the importance of these pathways in immune responses. Our strong track record of studies focused
on inflammasomes and pyroptosis has also allowed us to also make important discoveries about programmed
cell death pathways. We fundamentally advanced the field of cell death by identifying extensive molecular
crosstalk among seemingly distinct pathways. For example, we characterized Z-DNA-binding protein 1 (ZBP1)
as an innate sensor of influenza A virus that triggers the NLRP3 inflammasome and pyroptosis as well as
apoptosis and necroptosis (PANoptosis). We also identified that PANoptosis is mediated by a complex called
the PANoptosome, which provides a molecular scaffold that allows interactions and activation of the machinery
required for the inflammasome/pyroptosis, apoptosis, and necroptosis.
As a result of the significant progress made during the last funding period (which resulted in 129
peer-reviewed papers since the submission of this R37 5 years ago, including publications in Cell,
Nature, Nature Microbiology, Nature Immunology, and Immunity), we are now in an excellent position
to pursue new directions that will investigate the molecular, biochemical, and cellular mechanism of
inflammasome activation and PANoptosis in response to the global pathogen A. fumigatus. Our
recent studies demonstrated that the novel A. fumigatus PAMP galactosaminogalactan (GAG) activates the
NLRP3 inflammasome to drive cell death and in vivo protection against fungal-induced mortality. In addition
to inflammasome activation, we also recently discovered that A. fumigatus induces PANoptosis and that the
innate immune sensor ZBP1 is critical for driving inflammatory cell death. However, the molecular
mechanisms and signaling cascades that regulate and control these pathways, along with the implications of
PANoptosis in vivo, remain unknown.
In this grant application for extension of our R37, we propose to investigate the signaling pathways regulating
formation and activation of PANoptosomes driven by A. fumigatus infection. We will use a multifaceted
approach, employing cellular, biochemical, genetic, and unbiased large-scale screening experiments, to
identify key regulators and components of the PANoptosome and elucidate the fundamental molecular
mechanisms of PANoptosis. We will employ a CRISPR-based whole-genome functional screening approach to
determine which genes are essential for PANoptosis and to characterize their functions. We will treat a pool of
cells in which each non-essential gene in the genome is deleted in individual cells with A. fumigatus-derived
PANoptosis triggers and positive select for cells that are deficient in key PANoptotic components. We will then
perform next-generation sequencing to identify the disrupted genes. The power of this system presents a
tremendous opportunity to reveal novel sensors and regulators in PANoptosis. Furthermore, we will also
perform immunoprecipitations of the PANoptosome components and incorporate targeted and unbiased
proteomic approaches including mass spectrometry-based analyses and computational tools to identify and
characterize the full spectrum of PANoptosis components upon infection with A. fumigatus.
In addition to using molecular techniques to characterize the newly identified PANoptotic regulators, sensors,
and componenets, we will also analyze where in the PANoptotic pathway each of these molecules functions
using genetic approaches. We have developed advanced tools to study innate immunity, generating numerous
knockout mouse strains that will be critically important for evaluating the newly identified regulators and
members of the PANoptosome and PANoptotic pathway. As we have done with the PANoptotic regulators
previously identified in our laboratory, such as ZBP1, we will use these established models to systematically
dissect where these molecules fit into the pathway and rigorously test their roles in host defense against A.
fumigatus infection.
Continuation of this R37 and completion of our aims is expected to identify major innate immune
signaling pathways and the molecular mechanisms that regulate the PANoptosome and PANoptosis
in response to A. fumigatus. These discoveries are expected to identify novel signaling pathways that
could be targeted by therapeutic interventions.